TASK A92: Efficacy testing of therapeutics against Hepatitis B in a mouse model

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate products.